Oxygen-Guided Therapy for Optimal Rehabilitation for Peripheral Artery Disease

SUMMARY
This Workforce Diversity Supplement proposal seeks to create an opportunity to enhance the
resources, environment, and culture of Infrared Rx in our organization's efforts to advance
technology to serve patients suffering from disabling peripheral artery disease. At the same time,
it reflects our commitment to promoting a diverse workforce and to further career development for
underrepresented groups in science and business. In this proposal, we have created a role within
the organization for the candidate to expand knowledge, acquire skills, and shape attitudes in
science, medicine, and entrepreneurship. Meanwhile, this role will add value to our company, the
technology we develop, and the patients we seek to serve.

Public health relevance
Our central hypothesis is that NIRS-guided exercise programs can improve compliance with exercise prescriptions, decrease morbidity, and improve independence in older Americans with PAD. The following proposal will establish the foundation upon which we can develop a commercially viable software analysis platform that allows older adults to engage in exercise with 1) minimal pain and 2) on a self- directed basis. Successful development of this technology requires: 1) identification of the technical parameters needed to reliably make accurate NIRS measurements in older Americans with PAD; 2) automation of data-collection and analysis. In this administrative supplement, we seek support to diversity our team and provide opportunity for expanding knowledge, skills, and attitudes regarding science, medicine, and entrepreneurship.